Exploring Mechanisms Through Which STING Alleles Impact Clinical Penetrance of COPA Syndrome

Project Summary / Abstract
Interstitial lung diseases (ILD) are disorders in which lung inflammation and scarring cause reduced lung
function. When seen in the context of connective tissue disease (CTD), ILDs are treated with generalized immune
suppression as mechanisms driving disease remain poorly understood. COPA syndrome is a monogenic
autosomal dominant autoimmune disease causing CTD ILD that often progresses despite immune suppression,
with several patients with this rare disease requiring lung transplant. Importantly, this syndrome provides a model
for identifying disease pathways driving CTD ILD. Studies from the laboratory of Dr. Anthony Shum (my sponsor)
defined COPA syndrome and determined that disease is caused by failed retrieval of stimulator of interferon
genes (STING) from the Golgi to the Endoplasmic Reticulum (ER) by coatomer subunit α (COPA). STING, a key
innate immune adaptor, can only signal from the Golgi, and our group and others have shown that the pathogenic
mechanism causing COPA syndrome is constitutive STING activation and signaling.
COPA syndrome has a non-penetrance rate of ~30%, with unaffected carriers showing no signs of
disease. As STING drives pathogenesis of COPA syndrome, we hypothesized that STING alleles might act as
genetic modifiers impacting disease penetrance. Remarkably, we found perfect co-segregation of diseases non-
penetrance with heterozygosity for the common R71H-G230A-R293Q (HAQ) STING allele in 25 carriers of
pathogenic COPA mutations. As such, we propose HAQ STING as a suppressor allele for COPA syndrome.
This proposal seeks to define the mechanisms by which HAQ STING is protective in COPA syndrome.
STING is an ER-localized signaling hub for innate immune activation in response to cytosolic DNA.
STING activation results in interferon signaling and multiple other outputs including NFkB activation, autophagy,
senescence, and cell death. While HAQ STING has been shown to have impaired interferon signaling, this allele
is highly prevalent (over 30% of non-Africans have at least one copy) and is thus likely to be competent for some
but not all STING roles. How HAQ STING confers protection in COPA syndrome will be determined at many
levels. Differences in HAQ STING in the presence or absence of pathogenic COPA mutations will be established
at the mRNA and protein expression levels, through intracellular localization in resting and stimulated cells, and
via interferon dependent and independent read outs of STING activation. With STING implicated broadly in ILD
and other forms of lung inflammation, these studies hold potential for identifying novel therapeutic approaches
for COPA syndrome and other forms of ILD. Discovery of additional disease modifying approaches is critically
needed as ILDs have limited treatment options, resulting in high morbidity and mortality.

Public health relevance
Project Narrative COPA syndrome, an autosomal dominant monogenic disease causing autoinflammation and interstitial lung disease (ILD), results from defects in Golgi to Endoplasmic Reticulum retrieval of stimulator of interferon genes (STING) by coatomer subunit α (COPA). This proposal characterizing which STING functions are preserved or defective in a common STING allele that is associated with non-penetrance of pathogenic COPA mutations. STING hyperactivation has been broadly implicated in ILD, thus these studies hold potential to unlock novel therapeutic approaches for this group of morbid diseases.